Admin Core

ADMINISTRATIVE AND MENTORING CORE ABSTRACT
The Administrative and Mentoring Core will provide administrative leadership and direction for COBRE activities
across the two partner biomedical research institutions: the University of Maine (UMaine) and Mount Desert
Island Biological Laboratory (MDIBL). Dr. Clarissa Henry, COBRE PI and UMaine Professor of Biological
Sciences, will serve as the Core Director. She will be supported by two Associate Directors, senior personnel
with extensive NIH funding and leadership: Dr. David Harder, University Research Professor of Medicine
(UMaine) and Dr. Iain Drummond, Professor and Director, Davis Center for Aging and Regenerative Medicine
(MDIBL). Administrative and Mentoring Core activities will include oversight of the mentoring and pilot project
programs, oversight of the Steering, External Advisory, and Mentoring Committees, preparation of progress
reports, and overall program evaluation. The committee structure of this core intentionally engages leading
scientists from other biomedical research institutions in Maine, including Maine Medical Center Research
Institute (MMCRI) and The Jackson Laboratories (Jax). The Administrative and Mentoring Core will also be
supported by staff from the Office of the Vice President for Research and Dean of the Graduate School. This
core has four aims: (1) Provide administrative, scientific, and fiscal leadership, (2) Implement an effective career
development (mentoring) plan to facilitate the transition of junior faculty to independent RO1-funded
investigators, (3) Contribute to Maine’s interactive research network with regional research Institutions allowing
Center investigators to engage in collaborative research and enhance their COBRE experience, and (4) Evaluate
the proposed COBRE and establish a sustainable model. Taken together, these aims will ensure that the
research project leaders achieve independent RO1-level funding as well as transform the overall biomedical
research environment at the University of Maine.

Public health relevance
ADMINISTRATIVE AND MENTORING CORE NARRATIVE The Administrative and Mentoring Core will provide administrative leadership and direction for COBRE activities across the two partner biomedical research institutions: the University of Maine (UMaine) and Mount Desert Island Biological Laboratory (MDIBL). This core will ensure that the research project leaders achieve independent RO1-level funding as well as transform the overall biomedical research environment at the University of Maine.